Methods Core

The Specific Aims of the Methods Core are to support a shared infrastructure that will enable ETUDES
investigators to efficiently conduct the proposed Signature R01 which includes “Prediction and Assessment of
Risk in Teens” (PART) and “integrated Care to Help At-Risk Teens” (iCHART) RCT, and three R34 treatment
development studies described within this competitive renewal of our current P50 Center award. This Core will
also advance the development of several emerging technologies to identify youth at risk for suicide with a special
focus on engaging Black youth; advancing health equity; support and expand the number of early career
scientists (ECSs) engaged in adolescent suicide prevention research; and serve as both a local and national
resource sharing research expertise and new knowledge. The Methods Core will provide operational, analytic,
and development support to achieve these aims through: (1) Shared data management and statistical
collaboration to provide consistent and efficient support across all ETUDES Center studies; (2) Use of proven-
effective, HIPAA-compliant and scalable methods to identify and consent study patients and meet recruitment
targets without burdening busy providers and office staff; (3) Support for a centralized, well-supervised, highly
trained, and culturally-competent team of assessors who will confirm subject eligibility, administer a standardized
battery of baseline and follow-up assessments, and promote subject retention; (4) Support emerging smartphone
research methods including mobile sensing of smartphone data and an update of the psychologic autopsy for
the 21’st Century; (5) Machine learning and natural language processing of free-text unstructured electronic
health records to predict suicidal behavior; (6) Expertise in qualitative research methods and human-centered
design to engage patients, caregivers, and providers and iteratively improve our interventions and inform new
Center projects; and (7) Application of implementation science methods to ensure our predictive analytic
methods and interventions promote health equity and meet the needs of patients, caregivers, and providers in
pediatric primary care to optimize future uptake.